Biostatistics for Research in Genomics and Cancer

DESCRIPTION (provided by applicant): This 5 year program is designed to continue to train predoctoral (PhD) and postdoctoral students in statistical genomics with the major emphasis in cancer genomics. The goal is to train biostatisticians in the biology, etiology, and genetics of cancer, as well as to train them to conduct state-of-the-art biostatistical methodologic research relevant to the genomics of cancer as well as in related areas of genomics. The goal is to also produce biostatisticians who can collaborate with other scientific researchers and oncologists on research issues related to genomics and cancer. The typical predoctoral trainee will be a college graduate or master's level graduate with an excellent academic record appropriate for this training area. The typical postdoctoral trainee will have highly relevant doctoral training in statistics, biostatistics, or related areas. Funding is requested for the support of 5 predoctoral trainees and 1 postdoctoral trainee. The Department of Biostatistics at UNC is one of the largest in the world, and has highly qualified personnel and the available facilities to provide the most comprehensive predoctoral and postdoctoral training in this research area. Several members of the Carolina Center for Genome Sciences (CCGS) and the Bioinformatics and Computational Biology (BCB) program will be deeply involved in all phases of this training program and will play an integral role in this training program. PUBLIC HEALTH RELEVANCE: This training grant clearly has major relevance in public health as it is designed to train the next wave of biostatistical researchers in cancer genomics, which is one of the largest and growing areas of biomedical research, in which the demand for well trained biostatistical researchers is much greater than the supply.

Public health relevance
This training grant clearly has major relevance in public health as it is designed to train the next wave of biostatistical researchers in cancer genomics, which is one of the largest and growing areas of biomedical research, in which the demand for well trained biostatistical researchers is much greater than the supply.